Understanding the role of the nuclear pore complex in undifferentiated cell proliferation and gene gating

PROJECT SUMMARY / ABSTRACT
The nuclear envelope (NE), a double-membrane structure surrounding the cell nucleus, and the nuclear pore
complex (NPC), the largest protein assembly residing in the NE, together govern paramount cellular
processes of the eukaryotic life, spanning chromatin organization, gene expression regulation,
nucleocytoplasmic transport, and signal transduction. Our laboratory is committed to studying diverse and
novel functions of the NE and NPC using plants as our model organisms. Our emphasis on plants stems
from their unique combination of both conserved and distinct NE and NPC-associated mechanisms evolved
in response to complex environmental challenges. In this proposal, we aim to leverage an integrated
proteomic, molecular, genetic, and bioinformatic approach, to achieve a mechanistic understanding of how
PNET1, a newly identified and evolutionarily conserved NPC membrane component, impacts mitotic
progression in undifferentiated cells. Concurrently, we seek to elucidate the central role played by the NPC
basket protein, GBPL3, in the precise regulation of stress-induced transcriptional reprogramming through the
gene gating mechanism. This research endeavor is expected to significantly advance our understanding of
fundamental biological principles underlying cell division and the regulation of gene expression occurring at
the level of the NPC. Additionally, it may offer potential avenues for therapeutic interventions targeting
aberrant mitotic processes in critical human diseases (e.g., cancers) and provide insights into the precise
manipulation of gene expression, both in native and engineered biological systems.

Public health relevance
PROJECT NARRATIVE The nuclear envelope (NE) and the nuclear pore complex (NPC) embedded within the NE are vital structures for eukaryotic cells, and mutations in genes encoding NE and NPC components are intimately linked with a series of human diseases that are collectively known as nuclear envelopathies. However, our knowledge of the category and diverse functions of NE proteins in eukaryotic kingdoms, especially beyond humans and yeasts, remains limited. This research aims to comprehensively unravel the NE protein inventory in the eukaryotic life domain and explore novel, yet critical and conserved, roles of the NPC in facilitating rapid mitotic progression in undifferentiated cells and regulating gene expression via gene gating mechanism, which may offer key insights into fundamental cell biology and potential therapeutic avenues and impact fields ranging from genetics to medicine.